Anatomical Basis for Nicotine Addiction

PROJECT SUMMARY (See instructions):
Despite the necessary role of dopamine in nicotine reinforcement, it is not sufficient to explain the
complexity of addiction. Additional processes, particularly the ability of cues associated with nicotine
exposure to develop control over behavior, are essential for ongoing drug seeking. Both human subjects
and rodents experience reward-enhancement when exposed to nicotine. This has led to the idea that one
of the primary factors driving nicotine addiction is its ability to potentiate the value of other appetitive
stimuli and to accelerate cue-reward learning. The major achievement arising from this grant is the
discovery of a VT A-to-VP GABA circuit and a MS-to-BLA ACh circuit that increase responding for rewards
and reward-paired cues. We have now published manuscripts on characterization and manipulation of
these novel, potentially interacting, circuits, as well as on proteomic approaches to identify intracellular
pathways downstream of nAChRs in the VTA that contribute to cellular and morphological plasticity
following nicotine administration. Our new and updated Aims will expand on this progress by identifying
the role of nAChRs in these circuits, exploring cholinergic inputs to the VTA-to-VP GABA neurons,
identifying nicotine-dependent proteomic changes in BLA, and determining whether these pathways
interact to promote cue-reward behaviors. Together, these proposed studies will go beyond initial steps of
nicotine reward mediated through DA signaling to identify circuits and signaling pathways involved in the
ability of nicotine to potentiate rewarding responses, processes that likely contribute to long-term
susceptibility to nicotine addiction and relapse.

Public health relevance
RELEVANCE (See instructions): Nicotine addiction is responsible for the recent increase in vaping, and also drives tobacco smoking, the major preventable cause of death in the United States. One reason nicotine is addictive is because it makes other rewards feel even better. We will identify new brain mechanisms through which nicotine enhances experience of other rewards, and using molecular techniques, we will determine how these pathways contribute to behaviors related to nicotine addiction.